EVALUATION OF AEROSOLIZED RHDNASE IN PATIENTS WITH CYSTIC FIBROSIS

Accumulation of viscous infected secretions is typical of the lung disease in CF and improvement if pulmonary function will be studied in patients receiving recombinant DNase 1(rhDNase).